Institute for Food Safety and Health National Center for Food Safety and Technology Cooperative Agreement Renewal Application

The Institute for Food Safety and Health (IFSH) National Center for Food Safety and Technology (NCFST)
housed at Illinois Institute of Technology (Illinois Tech) is a food safety and applied nutrition research
consortium of the US Food and Drug Administration's Center for Food Safety and Applied Nutrition
(FDA/CFSAN), Illinois Tech, and the food industry. Since the establishment in 1988, NCFST has
successfully been providing a unique collaborative neutral ground where scientists with food safety and
technology expertise from academia, government, and industry join forces and work together to
address food safety, food defense, and nutrition issues of national significance. The successful results of
the past 35 years by the NCFST are due to this collaborative way of working. NCFST is structured so that
representatives of participating organizations play a role in helping establish policy and administrative
procedures, as well as identifying long- and short-term research programs that address FDA and industry
strategic needs. With this organizational structure, NCFST is uniquely positioned to build cooperative
food safety programs on a foundation of knowledge about current industrial trends in food processing
and packaging technologies, regulatory perspectives from public health organizations, and fundamental
scientific expertise from academia. The NCFST collaborative research programs are coordinated through
various inputs by participating representatives throughout the year. This includes regular meetings with
the Executive Advisory Board, the Science Advisory Committee, and various Science Forums advising and
recommending research topics in the five research platforms including Processing, Microbiology, Food
Chemistry and Packaging, Proficiency Testing and Method Validation Research, and Nutrition. With an
increasingly diverse domestic and global food supply, FDA continues to face complex food safety
challenges associated with foods that it regulates. In 2011, the enactment of the FDA Food Safety
Modernization Act (FSMA) emphasized the need for a modern, prevention-based food safety system.
Through the IFSH research consortium all parties work to help form a scientific basis for policy decisions
affecting food safety and public health. In addition, NCFST is the coordinator of the Food Safety
Preventive Controls Alliance (FSPCA), the Sprouts Safety Alliance (SSA), and the Juice HACCP Alliance,
leveraging the expertise of academia, industry, and FDA for the purpose of developing and delivering
standardized curricula related to FSMA requirements. The outreach on preventive controls provided by
these Alliances strengthens integral parts of the FDA's FSMA implementation strategies. IFSH will
continue to carry out multidisciplinary applied research; leverage collaborations with government,
academia, and the food industry; develop and implement outreach and communications programs with
stakeholders; and support the continued implementation of FSMA.

Public health relevance
PROJECT NARRATIVE Since 1988, NCFST has received support from the FDA under seven previously awarded cooperative agreements (53 FR 15736; 56 FR 46189; 59 FR 24703; 64 FR 39512; 69 FR 25405; 74 FR 26408; and 80 FR 43095). This five-year renewal award provides continued support to the collaborative research, education and outreach programs related to the safety of food processing technologies and processed foods, and further improves public health.